Cortical mechanisms of opioid reinforcement

PROJECT SUMMARY
This application outlines a program of research designed to better understand the molecular, cellular, and circuit-
based mechanisms of opioid use disorder (OUD). We recently showed that μ opioid receptors (μORs) are
densely expressed by neurons in the dorsal peduncular nucleus (DPn) of the ventral prefrontal cortex. Genetic
ablation of μORs from DPn neurons abolished the rewarding effects of opioids and instead rendered opioids
highly aversive. Disrupting μOR signaling in the DPn also exacerbated the severity of physical and affective
components of the opioid withdrawal syndrome, while chemogenetically silencing neural activity in the DPn
attenuated opioid withdrawal. Single-cell and spatial transcriptomics showed that μORs in the DPn are expressed
by an atypical population of cortical pyramidal neurons that also express vesicular glutamate transporter 2, which
densely innervate the parabrachial nucleus (DPnvGlut2àPBn neurons). These exciting new findings suggest that
DPnvGlut2àPBn neurons play critical roles in the behavioral actions of opioids that drive the development of OUD.
In this application, we will use cutting-edge molecular, cellular, and behavioral approaches to investigate the role
of DPnvGlut2àPBn neurons in the motivational properties of opioids. In AIM 1, we will use intersectional genetics
strategies to manipulate the expression of μORs in only DPnvGlut2àPBn neurons and thoroughly investigate the
consequences on intravenous (IV) opioid self-administration behavior. In AIM 2, we will use whole-cell
electrophysiological recordings combined with single-cell sequencing (PATCH-seq) to define the molecular
identity of the PBn neurons that receive direct excitatory synaptic input from DPnvGlut2 neurons (PBnDPn neurons).
We will then chemogenetically manipulate the activity of these PBnDPn neurons and determine the consequences
on IV opioid self-administration behavior. In AIM 3, we will use single-nuclei RNA sequencing (snRNA-seq),
single-nuclei spatial transcriptomics, and whole-cell electrophysiological recordings to define the transcriptional
and function adaptations that occur in DPnvGlut2 and PBnDPn neurons during the development of opioid
dependence. We will also investigate the behavioral consequences of chemogenetically manipulating the activity
of DPnvGlut2 and PBnDPn neurons on the expression of physical and affective components of the opioid withdrawal
syndrome. This highly innovative program of research builds on exciting new findings from our laboratory and
promises to yield fundamentally new insights into the neurobiological mechanisms of opioid addiction.

Public health relevance
PROJECT NARRATIVE How opioids act in the brain to drive opioid use disorder (OUD) is poorly understood. We recently identified a population of cortical pyramidal neurons that express μ opioid receptors (μORs) and project to the parabrachial nucleus (PBn). μOR-mediated inhibition of these cortical neurons was necessary for opioids to elicit their rewarding effects. Here, we will use a cutting-edge multidisciplinary approach to define the role of these newly identified cortical neurons in regulating the motivational properties of opioids that contribute to OUD. This program of research promises to yield important new insights into the mechanisms of OUD.